Cellular mechanisms of hippocampal network neuroplasticity generated by brain stimulation

Project Summary/Abstract
The distributed brain network of the hippocampus supports memory and related cognitive abilities. Disruptions
of this network occur in many neurological disorders such as epilepsy, brain injury, and neurodegenerative
disease. Brain stimulation targeting the human hippocampal network can produce long-lasting improvements
of memory ability, with corresponding increases in brain-activity markers of network function. However,
mechanisms for this beneficial network-level neuroplasticity caused by brain stimulation remain unknown.
Mechanistic knowledge is essential to optimize how and where to stimulate the hippocampal network in order
to maximize the resulting memory benefits. This project will investigate the cellular mechanisms for the effects
of brain stimulation on the hippocampal network. We will capitalize on the property that activity of regions of the
hippocampal network synchronize in the theta frequency band (5-8Hz) to test for mechanistic homology in the
effects of stimulation on human versus rodent hippocampal networks. In humans undergoing neurosurgery for
intractable epilepsy and in awake, behaving rodents, we predict that electrical stimulation will have greater
effects on hippocampal network function when it is delivered with increasing levels of synchronization to the
ongoing hippocampal theta activity rhythm. Thus, we will test whether the effects of manipulating the
synchrony between brain stimulation and hippocampal theta activity are comparable in humans and rodents.
The effects of stimulation will be assessed using measures of hippocampal network functional connectivity and
paired-associate memory performance that can be performed similarly in both species. We will then conduct in
vitro electrophysiology experiments in rodent brain slices obtained after stimulation in order to identify cellular
mechanisms for the effects of stimulation. We predict that stimulation parameters that increase hippocampal
network function will increase cellular excitability, as measured via the postburst afterhyperpolarization, of
dorsal hippocampal CA1 pyramidal neurons. Viral manipulation of CREB expression, which is necessary for
changes in excitability, will be used to causally test the role of dorsal hippocampal CA1 excitability in the
effects of stimulation on hippocampal network function. These research objectives are in close alignment with
the focus of RFA-NS-18-018 on establishing cellular mechanisms for the effects of brain stimulation on
neuronal circuits. Findings will uniquely uncover cellular mechanisms by which brain stimulation beneficially
impacts distributed brain networks and corresponding cognitive abilities. These mechanistic insights could
propel brain-stimulation treatments for memory impairments caused by disruption of the hippocampal network.

Public health relevance
Project Narrative This project seeks to determine cellular mechanisms for the effects of electrical brain stimulation on the hippocampal brain network that supports memory. It uses an integrated experimental approach across rodents and human neurosurgical cases to enhance the translational relevance of experimental findings. The knowledge gained could improve the ability to beneficially control hippocampal network function via brain stimulation in order to treat memory impairment.